Determining genetic mechanisms that drive in vitro hematopoiesis

PROJECT SUMMARY/ABSTRACT
This proposal focuses on how the Tropomyosin 1 gene product impacts the development of hematopoietic
stem and progenitor cells (HSPCs) and their precursors. There is considerable interest in augmenting in vitro
HSPC production from cultured induced pluripotent stem cells (iPSCs) to support research and development of
blood cell-based therapies. Defining genetic determinants of hematopoiesis is also relevant for understanding
benign and malignant blood disorders. We identified Tropomyosin 1 as a blood regulatory gene from human
genome wide association study data. We found that Tropomyosin 1 deficiency enhanced production of HSPCs
and their hemogenic endothelial precursor cells (HECs) in vitro and in vivo. Using transcriptomic and molecular
approaches, we found that Tropomyosin 1 loss enhanced TNFa signaling in cultured iPSCs and further
determined that TPM1-related TNFa signaling augmentation was responsible for increased hematopoietic
output. In Aim 1 of this grant, we will determine molecular mechanisms for how Tropomyosin 1 and actin
biology regulate the TNFa signaling pathway in HECs and HSPCs using translationally relevant iPSC culture
models. In Aim 2, we will determine if TPM1 deficiency increases the production of transplantable HSPCs
through TNFa-mediated effects on HECs.
My goal is to run a laboratory that integrates computational and biochemical approaches to understand genetic
mechanisms that enhance blood production, ultimately supporting cell therapeutics and regenerative medicine
applications to enhance human health. This proposal directly resulted from completion of the specific aims and
achievement of career development goals set forth in my K99 proposal, including rigorous training in data
science and hematopoiesis modeling. The three-year professional development program proposed in this R00
application will further propel my research career as an academic pediatric physician-scientist investigating
Tropomyosin 1 and other genetic mechanisms that regulate hematopoiesis. Having completed my clinical
training and having obtained a tenure-track appointment as an Assistant Professor of Pediatrics at the
University of Pennsylvania Perelman School of Medicine, I am well-supported at the institutional level. As I
develop my independent research program in this ideal academic environment, I will benefit from the
exceptional resources, core facilities, and collaboration with internationally recognized leaders in
hematopoiesis, human genetics, bioinformatics, and iPSC technologies at the University of Pennsylvania and
Children’s Hospital of Philadelphia for the duration of the R00 award period. After establishing my independent
research program with R00 support, I will be uniquely poised to compete for R01 funding as a successful
physician-scientist studying hematopoiesis genetics.

Public health relevance
PROJECT NARRATIVE. More efficient hematopoietic stem and progenitor cell (HSPC) generation from cultured induced pluripotent stem cells (iPSCs) would support translational research and cell therapies. Having identified Tropomyosin 1 as a blood regulatory gene from human genetic data, we used iPSC and murine models to determine that Tropomyosin 1 normally constrains HSPC production by modulating TNFa signaling. In this grant, we will determine the molecular basis for how Tropomyosin 1 regulates TNFa signaling to influence hematopoietic development and define its functional significance for blood cell derivation.